Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as "NOT-CA-
23-052: Economicsof Cancer Control in LMICs.” Childhood cancer survival rates are less than 20% in low-
and-middle-income countries (LMICs) compared to 80% in high income countries. A
LMICs
move
outcomes
stays,
distance,
driving
diagnosis
living
drive
identify
Zambia
out
who
cash
ensure
outcomes
Zambian
treatment
delivery
carry
administrators
and
developed
will
emphasizing
research
in
substantial challenge in
like Zambia is that l imited treatment locations in urban centers necessitate that hildren and caregivers
from more distant or rural places. Because of this, childhood cancer i s frequently diagnosed late when
are poor. Adding t o this, rural and distant patients and families in LMICs can have longer hospital
incur more expenses, nd are at greater risk of abandoning treatment. In effect, cost-driving factors (e.g.,
time, and treatment costs) further intersect with multiple social identities (e.g., poverty, rural i dentity),
further inequities in outcomes. Thus, elucidating and intervening in costs that delay and disrupt
and treatmen will be critical to improving access to diagnosis and t reatment for children with cancer
in distant, remote, and/or rural locales. Cash transfer interventions may address the multiple costs that
childhood cancer diagnostic and treatment delays, and treatment abandonment. Thus, our objective is to
modes of delivering cash transfers t o rural and remote childhood cancer patients and families in LMICs.
is an ideal setting to carry out cash transfer interventions t o improve childhood cancer outcomes. Nine
of every 10 children in Zambia with cancer do not reach either diagnosis or treatment, and 90% of those
do, abandon treatment or die before treatment ompletion Zambia also has one of the longest running
transfer programs in the region, but has no yet been used for treatable health conditions like cancer. To
the appropriateness and sustainability of cash transfers o reduce costs and improve treatment
for rura l and remote children with cancer, we propose two aims with strong support from the
Ministry of Health. Aim 1: To identify the multiple costs associated with cancer diagnostic and
delay and abandonment for children from distant locales. Aim 2: Determine mechanisms for the
and sustainability of cash transfers for childhood cancer care at the healthcare system level. We will
out document review, participatory workshops, and meetings with legislative members and health system
to adapt cash transfers to the health system. Upon completion, we will have identified t he formal
informal costs that drive childhood cancer diagnostic and treatment delay and abandonment and
a pathway for introducing a treatment f ocused cash transfer intervention for childhood cancer. We
use these findings to propose an R01 to carry out a hybrid type 2 trial of this cash transfer intervention,
cost and sustainability as implementation outcomes. Successful completion wil l also foster the
careers of promising j unior members of our LMIC research team, a necessary step to build capacity
Zambia and in global cancer equity researcher and leadership.
c
a
t
c .
t
t

Public health relevance
PROJECT NARRATIVE Cure rates for childhood cancer in Zambia are low, and significant unmet costs hinder access to childhood cancer diagnoses and treatments, particularly for rural patients and those far from treatment. Our study will identify the formal and informal costs that affect childhood cancer diagnosis and treatment for children living far from cancer treatment. By including government input into designing the form and function of a cash transfer intervention for childhood cancer, we will ensure that our next step upon completing the study, a cash transfer program for childhood cancer, is both acceptable and feasible within the current policy environment.